Elucidating the Origin of Sudden Cardiac Death in Dilated Cardiomyopathy: from Phenotype Predictors to Therapeutic Targets

Project Abstract
The molecular mechanisms and the clinical predictors of life-threatening arrhythmias in patients with dilated,
nonischemic cardiomyopathy (DCM) remain elusive, hampering adequate prevention and treatment of sudden
cardiac death (SCD) and malignant ventricular arrhythmias (VA) in this population. Our application will address
this unmet need. Our established team of investigators from the University of Colorado and Stanford University
has assembled preliminary data and proof-of-concept experiments to tackle three complementary aims, which
will comprehensively fill critical knowledge gaps in life-threatening VA and SCD risk in DCM. We hypothesize
that two main mechanisms are involved in VA/SCD in DCM: genetic factors (“arrhythmogenic” genes) and
cardiac fibrosis. We will address these hypotheses with three independent but complementary Specific Aims
(clinical, translational and mechanistic) designed to translate the discovery of mechanisms and delineation of
prognosis into a precision medicine approach. Specific Aim 1 will define genotype and phenotype
predictors of malignant VA and SCD in DCM. Our preliminary studies show that phenotype, such as
myocardial fibrosis, and gene mutations significantly increase the risk of VA/SCD. Thus, we hypothesize that a
clinical multidisciplinary approach including genotype and advanced imaging can precisely identify DCM patients
at risk of SCD. Using deep phenotyping, outcome measures, and NextGen sequencing in the Familial
Cardiomyopathy Registry (1,316 DCM subjects), we will generate a SCD risk prediction score for clinical use.
Specific Aim 2 will identify the transcriptome signature of VA. We found that explanted hearts of patients
with arrhythmogenic DCM have a distinct transcriptional signature. Thus, we hypothesize that, in advanced-
stage DCM, lethal arrhythmias are driven by genetically determined transcriptional signatures. We will leverage
whole genome and transcriptome sequencing data from our NIH/NHLBI TOPMed project (X01 HL139403: 1078
explanted hearts, 504 DCM, 140 controls) to identify gene-specific dysregulated pathways predicting high-risk
VA. Specific Aim 3 will elucidate the molecular mechanisms of arrhythmogenic genes. Our preliminary
data in mutant human induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CM) show evidence of
intrinsic electrical instability. However, the role of cardiac fibroblasts and CM/CF cross-talk in arrhythmogenesis
remains unknown. We hypothesize that arrhythmogenic DCM genes activate fibroblasts and induce arrhythmia,
either directly or indirectly through their interaction with cardiomyocytes. hiPSC-CM and cardiac fibroblasts
(hiPSC-CF) will be generated from 60 patients from our Registry (Aim 1) and genome edited models with
mutations in arrhythmogenic genes (LMNA, FLNC, DSP), and 20 age/gender/ethnicity-matched healthy
individuals. Using engineered heart tissue scaffolds (EHT), we will elucidate the mechanisms of CFs activation
and arrhythmia, compare altered signaling pathways in iPSC-derived models with those in the explanted hearts
cohort (Aim 2), and pharmacologically rescue the phenotype.

Public health relevance
Project Narrative Patients with dilated, nonischemic cardiomyopathy (DCM), even in the absence of severe cardiac dysfunction, may be at high risk for life-threatening ventricular arrhythmias and sudden cardiac death. However, current paradigms are insufficiently sensitive to correctly identify patients with ‘arrhythmogenic’ DCM who are at risk. Our application is built around this unmet need: we will generate a ‘risk stratification score’ that can be used as a clinical tool, uncover the molecular mechanisms triggering arrhythmias in these patients, which are currently unknown, and dissect the mechanisms of lethal fibrosis, thus paving the way for development of novel therapeutic strategies.